Monoclonal antibody isolation and characterization

We have isolated more than 40 HIV-specific antibodies (Abs) from rhesus macaques that were protected against repeated HIV challenge following prime-boost vaccination with mRNA expressing HIV immunogens. We are screening these Abs for neutralization breadth against HIV-1.

For Nipah virus antibody discovery, we are isolating NiV-specific mAbs from human peripheral blood mononuclear cell (PBMC) samples from study VRC322 in which individuals received prime-boost vaccination with mRNA-1215 expressing secreted pre-fusion stabilized NiV fusion (F) protein covalently linked to NiV glycoprotein (G). So far we have isolated more than 60 NiV-specific neutralizing Abs which are being characterized for neutralization potency, and cross-neutralization of related henipaviruses, including Hendra virus (HeV). We have filed a provisional patent for several of our Nipah virus-specific antibodies.